SOLAir: Environmental Factors and Diabetes Development in Latinos

PROJECT SUMMARY
This diversity supplement will build on the SOL Air ancillary study to the Hispanic Community
Health Study/Study of Latinos (HCHS/SOL), and provide research and training experience to a
qualified early career trainee. The funded study, SOL Air, focuses on the relationship between
exposure to traffic-related air pollutants (PM2.5, nitrogen dioxide (NO2), nitrogen oxides, (NOx), and
ozone (O3)) and incident type 2 diabetes (T2D), using a fine-scale spatiotemporal model to predict
long-term exposure levels at participant’s residential addresses. Longitudinal health data is collected
by the HCHS/SOL. The diversity supplement will allow for additional investigation into how the
relationship between air pollution and T2D is modify by diet. Utilization of the HCHS/SOL cohort
allows us to investigate relationships between and within various Hispanic/Latino heritage group.
Longitudinal health data and 24-hour dietary recall questionnaires have been collected in all SOL
study participants.
The prevalence of T2D is increasing, especially among younger adults and Latinos. Risk of
T2D has been linked to lifestyle factors such as an individual’s diet and activity levels. Long-term
exposure to ambient air pollution has also been linked to increased risk of incident T2D. Previous
research on ambient air pollution has mainly focused on particulate matter (PM2.5) and there is a high
level of heterogeneity between studies. Additionally, little prior research has focused specifically on
the US Hispanic/Latino population.
We will examine the interaction between an individual’s diet, measured by the Alternative
Healthy Eating Index (AHEI-2010), and long-term ambient air pollution exposure to determine if those
following a certain diet have a different risk of developing T2D using Poisson regression models.
Further analysis will include the heritage and acculturation of participants as diet may be impacted by
participant’s heritage and how long they have lived in the US. Our findings will contribute to the
research on the interplay of diet, air pollution, heritage, and T2D risk in an underrepresented research
population.

Public health relevance
PROJECT NARRATIVE This project will contribute to the ongoing investigation of diet’s role in the association between air pollution exposure and type 2 diabetes. Using the comprehensive data collected by the Hispanic Community Health Study/Study of Latinos, our analysis centers around the Hispanic/Latino community, a historically underrepresented community in research. Understanding the interactions between diet and air pollution could help reduce incidence of T2D by identifying persons at higher risk and linking a healthy diet as a protective factor.